Methodology Core

ABSTRACT - METHODOLOGY CORE
Clinical research in total joint arthroplasty (TJA) demands the highest standards of study design while
leveraging existing data sources and adopting standardized definitions and novel clinical research
methodologies. TJA researchers need to be well-trained and supported if they are to respond effectively to
current and emerging research gaps in TJA. The Mayo Clinic American Joint Replacement Research-
Collaborative (AJRR-C) is a Core Center for Clinical Research exclusively focused on TJA. AJRR-C
Methodology Core builds upon Mayo’s existing methodology resources to advance the science of TJA clinical
research at the national level by providing high-quality consulting, education and mentoring services, and
state-of-the-art and novel methodology resources, facilitating optimal use of existing databases and clinical
research networks, training of the next generation of TJA clinical investigators and building scientific
collaborations.
The Specific Aims of the AJRR-C Methodology Core are: (1) To enhance TJA clinical research at the national
level by providing consultation, education and mentoring services to TJA investigators, (2) To leverage existing
databases and clinical research networks to identify the most informative study populations and study designs
for TJA clinical research, and (3) To develop and disseminate novel methodologies applicable to observational
and interventional study designs in TJA clinical research. The Methodology Core focus on 6 specific
methodological areas in TJA research: methods to account for bias and confounding in TJA research,
disparities in access to TJA and outcomes, application of TJA-specific informatics tools for automated data
extraction from the electronic health records, patient-reported outcomes research, clinical trials embedded in
registries and/or healthcare systems, and implementation research. The AJRR-C Methodology Core will
ensure a flexible, sustainable research infrastructure, trained workforce and synergistic collaborations at the
national level.

Public health relevance
NARRATIVE The American Joint Replacement Research Collaborative (AJRR-C) provides methodological expertise and access to nationwide data resources to facilitate innovative, methodologically rigorous and interdisciplinary clinical research in TJA. The clinical research needs of the TJA research community that are addressed by the AJRR-C include training of the next generation of TJA researchers, customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as informatics and methodology support.